Epigenetic Regulation of Nuclear cGAS Activity in Aging-Related Inflammation

PROJECT SUMMARY
Chronic inflammation is a hallmark of aging and plays a key role in the development of numerous
neurological disorders. In the mammalian innate immune system, cyclic GMP-AMP synthase (cGAS) detects
foreign or damaged endogenous DNA, synthesizes the second messenger 2’3’-cGAMP, and activates STING
to promote the production of type-I interferons and interferon-stimulated genes. While recent studies suggest
that activation of nuclear cGAS is critical in aging-related inflammation and neurodegeneration, the
mechanisms by which nuclear cGAS is activated to drive chronic inflammation during aging remain poorly
understood. Our preliminary findings reveal an unexpected link between chromatin regulation and cGAS
activation, potentially explaining how cGAS contributes to aging-induced chronic inflammation. We
discovered that cGAS, which is predominantly enriched in the nucleus and bound to nucleosomes in an
inactive state, is released and activated by histone H4 N-terminal tail acetylation. Moreover, we found that
BRD4, a known reader of H4 acetylation, binds acetylated H4-containing nucleosomes and further enhances
cGAS activation. Since increased H4 acetylation is a hallmark of aging, we propose that aging-related histone
hyperacetylation leads to the release and activation of nuclear cGAS, driving chronic inflammation and
contributing to age-related diseases. Our central hypothesis is that specific patterns of histone H4 acetylation,
along with their reader proteins, represent a novel regulatory mechanism that unleashes and activates
chromatin-bound cGAS, contributing to inflammation and aging. If validated, these findings would introduce a
new paradigm for understanding how nuclear cGAS drives aging and could pave the way for therapeutic
strategies targeting H4 acetylation and BRD4 to control inflammation during aging. To test this hypothesis,
we have assembled a multidisciplinary team with expertise in structural biology, biophysics, biochemistry, cell
biology, chromatin biology, and epigenetics. Together, we will pursue three specific aims: (1) decipher the
histone H4 acetylation patterns that regulate the activation of nucleosome-bound cGAS, (2) elucidate how H4
acetylation readers activate nucleosome-bound cGAS, and (3) investigate the physiological roles of H4
acetylation-dependent nuclear cGAS activation in cellular senescence and aging. This research, spanning
from atomic structures and mechanistic insights to genetic models and animal pathology, offers an innovative
concept and framework to advance our understanding of nuclear cGAS regulation in chronic inflammation.
The potential findings could uncover a new paradigm at the intersection of epigenetics, innate immunity, and
aging, and facilitate the development of cGAS-targeted therapies for age-related disorders.

Public health relevance
PROJECT NARRATIVE Human aging is linked to epigenetic changes, including increased histone H4 acetylation. Spanning from atomic structures to animal models, the proposed research will explore a novel connection between H4 acetylation and the activation of nuclear cGAS that drives chronic inflammation during aging, hence facilitating the development of targeted therapeutics for age-related human disorders.